25th International Workshop on Long-term Complications of HIV and SARS-CoV-2

With the success of antiretroviral therapy (ART), comorbid diseases are now the leading causes
of death and disability in people living with HIV around the globe, including in low- and middle-
income countries (LMIC). Large meetings are important venues for scientific exchange regarding
the latest advances in HIV Comorbidity research, but smaller, more intimate formats that
emphasize discussion and networking are critical to the career development of HIV Comorbidity
investigators. In addition, there is a need for a forum for scientific exchange regarding post-acute
sequelae of COVID-19 (PASC), a poorly understood syndrome which may share pathogenic
features with HIV comorbidities and, as a result, has attracted the interest of many HIV
Comorbidity researchers. Our workshop, now in its 25th year and renamed the International
Workshop on Long-term Complications of HIV and SARS-CoV-2, provides <200 international
delegates with an opportunity to come together to discuss the latest findings and controversies in
HIV Comorbidity and PASC research in a one-room, two-day format. Plenary speakers are either
noted experts from outside of HIV research or HIV researchers with expertise in a specific
comorbidity. A highly interactive PASC roundtable, with 2 mini-talks, highlights critical and
emerging issues in the pathogenesis and management of PASC. Abstract presentations
including 24 15-minute talks and a poster session provide ample opportunity for researchers to
present and get feedback on their latest work. With this R13, we propose to enhance the 25th
Workshop (December 14th/15th at the NIH in Rockville, MD) with the following aims: 1) to provide
a forum for the latest HIV Comorbidity research in LMIC by offering travel scholarships to LMIC
investigators, supporting an internationally recognized expert in non-communicable diseases in
LMIC as a plenary speaker, and liaising with international training programs, 2) to provide a
continued and expanded forum for discussion and dissemination of the latest research findings
regarding PASC, 3) to support early-stage HIV Comorbidity and PASC investigators with a highly
innovative day-long Career Development Studio prior to the Workshop (December 13th). By
providing a “scientific home” to HIV Comorbidity and PASC investigators from around the world,
we hope to catalyze future research efforts in HIV Comorbidities and PASC and facilitate the
translation of research findings into clinical strategies that can improve the lifespan and
healthspan of PLWH and those with long COVID.

Public health relevance
Narrative The International Workshop on Long-term Complications of HIV and SARS-CoV-2 is a unique forum for scientific exchange on HIV Comorbidities and Post-Acute Sequelae of COVID-19 (PASC). We propose to enhance the 2023 Workshop by providing scholarships to early stage investigators (ESI) from low and middle income countries, and a day-long Career Development Studio on the NIH campus for ESIs interested in HIV comorbidities and long COVID, coordinated with the NIH Office of AIDS Research.